Administrative Core

Core A: Administrative Core, Core Leader: Michael Brenner, MD, PhD
The proposed administrative core will help ensure the success of the Program Project by providing
administrative management for the three program projects and the Computational Systems Immunology Core
(scientific core). The proposed program consists of three, highly synergistic research projects that involve the
use of shared material, data and experimental and technical resources across projects and with the cores.
Lead by Michael Brenner, the Administrative core will ensure smooth communications within the program; will
monitor milestones and timelines; will ensure fiscal accountability and management of subcontracts; will assure
regulatory compliance, will facilitate review and quality assessment of ongoing research by the external
scientific advisory group; and will identify and help resolve any disputes that arise during the grant period.